Regulating host neural activity to improve retinal ganglion cell replacement therapies

Project Summary
Glaucoma is a neurodegenerative disease that causes irreversible vision loss due to the death of retinal
ganglion cells (RGCs). Prior studies, including ours, reveal that while cell transplantation can replace lost RGCs,
most donor RGCs still fail to integrate within the host retina.
Since the mammalian retina cannot regenerate naturally, we must provide exogenous cues to control the
retinal microenvironment and support RGC regeneration. Previously, I demonstrated that introducing chemokine
gradients and inhibiting subtype-specific avoidance mechanisms can improve the structural integration of donor
RGCs in the retina. However, not all donor RGC structural integrate, and there is limited evidence of functional
donor-host neuron connectivity, suggesting unknown factors limit donor RGC integration.
I hypothesize that neural activity, a major regulator of plasticity, is potentially limiting donor neuron
integration. Therefore, I aim to investigate the role of neural activity in RGC integration in the retina to improve
functional connections with existing visual neurocircuitry. Furthermore, by establishing a model for manipulating
host RGC neural activity, we can selectively inhibit neural activity during electrophysiological recordings to
distinguish donor RGC activity from host neurons and quantify functional integration at scale.
Using this same endogenous RGC inactivation model, we can decouple neural activity from cell death (Aim
1) and inhibit retinal neuron activity during and after transplantation (Aim 2) to investigate the role of neural
activity in host and donor visual neural circuit remodeling. Aim 1 will focus on retinal remodeling following a period
of RGC inactivation, while Aim 2 will investigate if inhibiting host neural activity can improve donor RGC structural
and functional integration. The K99 phase will focus on model characterization and the role of neural inhibition
on RGC structural characteristics, with the R00 phase extending this focus to those same RGCs but to their
functional characteristics.
Altogether, by controlling host neural activity and transplanting donor neurons in my endogenous RGC
inactivation model, we aim to improve RGC replacement therapies and quantify the remodeling of host and donor
visual neural circuits. I aim to build upon this research project to establish a strong foundation for my independent
research program on neural plasticity in the visual system. During the K99 phase, I will expand my expertise in
regenerative ophthalmology to accomplish my aims by studying visual neural circuit remodeling. This work will
dovetail into my independent research program focusing on donor-host neural connectivity. The training portion
of this proposal will take place at Schepens Eye Research Institute of Mass Eye and Ear, which offers
unprecedented access to research equipment and faculty expertise to assist in accomplishing my goals.

Public health relevance
Project Narrative Due to an inability of the mammalian retina to regenerate, retinal ganglion cell (RGC) death in glaucoma and other optic neuropathies leads to irreversible vision loss. Cell transplantation is a promising approach for replacing RGCs; however, most stem cell-derived donor RGCs fail to integrate into the mature, electrically active host retina. This proposal will investigate the role of neural activity in donor and host RGC connectivity and function to improve donor RGC integration and broaden our understanding of neural plasticity in degenerative diseases in the retina and beyond.